Regulation of NF KappaB Dependent Genes by Estrogen Receptor

Infection of human coronary smooth muscle cells (SMC) with cytomegalovirus (CMV) causes generation of reactive oxygen species (ROS) and release of tumor necrosis factor-alpha(TNF). We have previously shown in CMV or TNF-activated SMC that estrogen (E, 0.1-10 nM) attenuates: 1) ROS generation, 2) Nuclear Factor (NF)kappa-B- dependent transcription of the major immediate early promoter of CMV upstream of the chloramphenicol transferase gene (MIEP-CAT), and of a 3X-kappaB-CAT reporter (containing 3-kappaB binding elements in tandem), 3) expression of protein products ICAM-1 (intercellular adhesion molecule), and of CMV-IE72 (which activates MIEP-CAT and ICAM- CAT). Although effects of E at nanomolar concentrations are due partly to direct antioxidant actions, we hypothesized that E effects on signaling mechanisms via its receptor (ER) might also play a role. To determine whether SMC might express ER, we exposed cells to E (10 nM) for 72 hours. After that we detected ERbeta , but not ERalpha(by immunocytochemistry and by Western blot). Transfection of SMC with 3X- kappaB-CAT or ICAM-CAT and the kappaB-subunit p65 caused a 10-fold or 5-fold increase, respectively, in promoter activity. By cotransfecting these SMC with increasing amounts of ERalpha , we now demonstrate that ER dose-dependently inhibits p65-dependent activation of 3X-kappaB-CAT, and of ICAM-1-CAT (contains 1 kappaB-site essential for promoter activation). The kappaB-subunit p50 was ineffective in activating the ICAM promoter. Treatment with E increased interference of ER with p65. We conclude that E may have anti-inflammatory effects due to ER- mediated interference with NF-kappaB-dependent transcription of genes that encode inflammatory proteins. - human cornary SMC, transcription factors, NF-kappaB, estrogen receptors, atherosclerosis